Biomaterial technologies to train innate immunity

PROJECT SUMMARY
Persistent inflammation can lead to trained innate immunity, or alterations in the innate immune response to
future stimuli. Trained innate immunity has a wide variety of practical consequences both protective and
deleterious. Despite the widely recognized impact on host immune response, very little effort has been put forth
towards engineering trained innate immunity towards a desired phenotype. The goal of this study is to therefore
establish the feasibility of engineering trained innate immunity using biomaterial implants. All implanted
biomaterials elicit some degree of foreign body response that mimics the pathological conditions that lead to
trained innate immunity and thus provides a potential avenue towards engineering this response. We have
previously observed practical, long-lasting changes in the innate immune response to toll-like receptor
stimulation using an implanted poly(ε-caprolactone) scaffold, thus supporting the hypothesis that this type of
technology is a viable means of controlling the systemic innate immune response. We therefore plan to
investigate two foundational aspects of scaffold-mediated trained innate immunity. Our first aim will focus on the
effects of pore size and degradation time on innate immune training. We will fabricate macroporous scaffolds
from poly(lactide-co-glycolide) with tunable degradation and pore size, implant these scaffolds into mice, and
monitor innate immune phentoype through isolation of immune cells or induction of periodontitis. Our second
aim will establish the aspects of the foreign body response necessary for innate immune training. Bone marrow
transplants will determine the effects of immune cell recruitment to the scaffold on training, while cell type
depletion and single cell transcriptomics will determine the impact of individual cell lineages on scaffold-mediated
innate immune training.

Public health relevance
PROJECT NARRATIVE Trained innate immunity is a potential immunoengineering avenue to protect against cancer or infectious diseases, yet no reliable strategy currently exists to control this response. Implanted biomaterials can elicit a foreign body response that is the type of inflammatory reaction necessary for innate immune training. The purpose of this study is to examine the ability to engineer trained innate immunity through controlling the foreign body response to implanted biomaterial scaffolds.